Intervention to Reduce Depression Among Elder Abuse Victims: Type 1 Hybrid Trial of Tele-PROTECT

PROJECT ABSTRACT
The World Health Organization estimates that 1 in 6 adults over the age of 60 has been a
victim of abuse in the past year. Our research demonstrated that nearly one-third of these
victims have clinically significant depressive symptoms and 16% have suicidal ideation (Sirey et
al., 2015). Tele-PROTECT, is the only manualized, virtual therapy for elder abuse victims
experiencing depression. It is offered to victims at the same time that they are receiving services
from elder abuse agencies that offer safety planning, support services, and legal services. Tele-
PROTECT was designed using a deployment-focused approach with our partners at the New
York City Department for the Aging (DFTA). Tele-PROTECT strategies focus on increasing
pleasurable and rewarding activities to reduce depression, and goal setting and defining the
action steps to increase safety related empowerment. In our randomized controlled pilot project,
participants receiving PROTECT had significant decreases in symptoms of depression as
compared to those in the referral control condition (Sirey et al., 2021). Our preliminary work
during the pandemic, demonstrated the feasibility and effectiveness of virtual delivery of
PROTECT via video (called Tele-PROTECT) to a large sample of diverse victims.
This project will test the effectiveness of Tele-PROTECT as compared to a video-delivered
attention control condition (DepEd). We will recruit 140 English- and Spanish-speaking elder
abuse victims from five New York City (NYC) elder abuse agencies. We hypothesize that Tele-
PROTECT participants will experience greater decreases in depressive symptoms and greater
increase in safety-related empowerment compared to an attention control (DepEd).
Elder abuse agency staff will refer depressed victims who agree to research staff. Eligible
elder abuse victims who consent, have a baseline assessment and meet inclusion criteria will
be randomized to Tele-PROTECT or DepEd. Follow up assessments will be conducted at
weeks 3, 6, 9, and 12 after baseline. Trained Research Assistants blinded to study hypotheses
will assess depression severity (MADRS) and safety-related empowerment (MOVERS), as well
as participation in activities, social isolation, and criminal justice outcomes. In collaboration with
a national organization of elder abuse agencies (NAPSA), we will use a mixed methods design
with multiple stakeholder groups to collect data on the barriers and facilitators to the
implementation of Tele-PROTECT nationally. Tele-PROTECT has demonstrated feasibility,
acceptability, and preliminary effectiveness. This project will test a scalable manualized therapy
with the potential for national implementation to serve depressed victims of elder abuse.

Public health relevance
PROJECT NARRATIVE Considering the rates of elder abuse in the Unites States are growing and many victims have depression and are not receiving care, we propose a randomized controlled trial (N=140) of Tele-PROTECT compared to a video-delivered depression education (DepEd) intervention to test the effectiveness of our behavioral therapy (Tele-PROTECT) specifically targeting older adult victims of abuse. The goal of Tele-PROTECT is to reduce symptoms of depression and support empowerment to take steps to ensure safety for older adults living with abuse and depression, to be delivered via video in English and Spanish, in tandem with the participant’s elder abuse services. The proposal will identify potential barriers and supports for implementation, with the ultimate goal of disseminating Tele-PROTECT nationally to address the widespread needs of this vulnerable older adult population.